Bayesian estimation of gene effects on traits from coding variants

Abstract
One central goal of human genetics is to determine the key genes and molecular pathways that drive disease.
By doing so, we can hope to gain deeper insight into the molecular basis of disease, as well as to identify
potential targets for therapeutic intervention. While GWAS has identiﬁed tens of thousands of signiﬁcant, robust
associations, the results do not provide a straightforward assessment of the potential importance of each gene.
As an alternative, we propose to develop new techniques for using rare protein-coding variants including loss-
of-function mutations, deletions, and duplications in burden tests. We will use these to estimate the magnitude
and direction of effect of each gene on a phenotype of interest, across the full range of expression encompassed
by natural variation. In order to improve accuracy, since tests at single genes are often underpowered, we will
extend a machine learning approach we developed previously called GeneBayes to share information among
similar genes within a hierarchical Bayesian framework. We will release open access software and summary
statistics to maximize the value of our work to the scientiﬁc community.

Public health relevance
Project Narrative The goal of this project is to develop new statistical and machine learning techniques to estimate the importance of each gene for driving effects on human traits and diseases. Software and results will be made freely and publicly available. This work will be useful for understanding disease mechanisms and identifying potential points of clinical intervention.